Leveraging experimental and computational tools to define molecular functions of non-coding RNAs in innate immune responses to viral infection

We seek to characterize the roles and functions of newly identified lncRNA ZFAS1 and its SNORDs both in vitro and in vivo contexts of viral infection and nucleic acid sensing.

Public health relevance
Long non-coding RNAs (lncRNAs) have recently emerged as a key level of regulation and complexity in innate immunity through many different mechanisms ranging from activating or repressing NF-kB signaling, regulating TLR signaling, and altering chromatin modifications. Using a combination of an in silico computational platform, together with rational experimental perturbations, we have identified lncRNA ZFAS1 and its SNORDs as putative regulators of cytosolic sensing on nucleic acids. We seek to further characterize the roles and functions of the ncRNAs both in vitro and in vivo contexts of viral infection and nucleic acid sensing.